MOTHER AND INFANT HOME VISITING PROGRAM EVALUATION, LONG-TERM FOLLOW-UP 2 (MIHOPE-LT2)

The purpose of this project is to examine the long-term effects of the Maternal, Infant, and Early Childhood Home Visiting (MIECHV) Program on children and families. This includes collecting data from participants in the Mother and Infant Home Visiting Program Evaluation (MIHOPE) when the children are in kindergarten; analyzing data and supporting others’ analyses of data collected from MIHOPE participants, and disseminating findings.